Anxiety diagnostic accuracy in VA primary care mental health integration settings: Identifying barriers and facilitators to inform a learning health care system

Anticipated Impacts on Veteran's Healthcare: The provision of high quality healthcare requires accurate
and timely diagnosis. The National Academy of Medicine asserts that “Improving the diagnostic process is not
only possible, but also represents a moral, professional, and public health imperative.” Identifying factors
influencing diagnostic accuracy is essential to improving the diagnostic process. The proposed study will
identify factors associated with anxiety diagnostic errors in VHA primary care mental health integration
(PCMHI) and specialty mental health (MH) settings, and addresses HSR&D priority areas "Mental and
Behavioral Health” and “Health Care Systems Change” and the ORD-wide priority area “Learning Health Care
System”
Project Background: VHA has little information about specific determinants of current anxiety diagnostic
practices and the sociotechnical context in which diagnoses are made. Unspecified anxiety disorder is the
most common anxiety-related diagnosis in VHA but is often a diagnostic error. In FY2017, 408,250 Veterans
enrolled in the VHA carried an unspecified anxiety disorder diagnosis, and unspecified anxiety accounted for
70% of anxiety diagnoses in PCMHI that year. However, the majority of these diagnoses are erroneous as
fewer than 3% of Veterans diagnosed with unspecified anxiety meet DSM-5 criteria for this disorder. Accurate
diagnosis is foundational to evidence-based healthcare, and 77% of Veterans diagnosed with unspecified
anxiety meet diagnostic criteria for a specific anxiety or trauma-related disorder (generalized anxiety disorder
[GAD, 44%]; posttraumatic stress disorder [PTSD, 38%]; panic disorder, 20%; social anxiety disorder 20%).
Diagnostic accuracy is critical to accessing appropriate services. Only 32% of Veterans with unspecified
anxiety disorder received mental health services in the year following diagnosis, compared to Veterans
diagnosed with GAD (60%), panic disorder (67%), and social anxiety disorder (88%). Thus, an erroneous
diagnosis of unspecified anxiety disorder is a barrier to receipt of appropriate evidence-based care for specific
disorders such as PTSD, GAD, and panic disorder.
Project Objectives: The proposed, 3-year, multisite study will use mixed quantitative and qualitative methods,
informed by the Safer Dx framework, to identify system-, provider-, and patient-level factors associated with
anxiety diagnostic specificity in VHA PCMHI and specialty MH settings. Understanding how these factors
interact in the anxiety diagnostic process is crucial to identifying point(s) in the diagnostic process at which to
intervene.
Project Methods: The aims of the proposed project will be achieved through three major activities that will be
carried out using mixed, qualitative and quantitative, methods. Aim 1 will use administrative data from the
Corporate Data Warehouse (CDW) to identify system-, provider-, and patient-level factors associated with
anxiety diagnostic specificity in PCMHI and specialty MH settings. Aim 2 will consist of qualitative interviews
with PCMHI and specialty MH providers to understand their perspectives on barriers and facilitators to anxiety
diagnostic specificity. Aim 3 will identify barriers to anxiety diagnostic specificity in each phase of the
diagnostic process outlined by the Safer Dx framework. This aim will be achieved through chart reviews and
diagnostic interviews of patients diagnosed with unspecified anxiety disorder, as well as critical incident
interviews with PCMHI and specialty MH providers.
Next Steps: Findings from this study will position the research team to design and test a tailored intervention
to facilitate mental health providers' accurate and timely diagnosis of anxiety- and trauma-related disorders for
Veterans.

Public health relevance
Unspecified anxiety disorder is the most prevalent anxiety diagnosis in VHA mental health settings, yet the majority of Veterans diagnosed with unspecified anxiety meet diagnostic criteria for an alternate, specific anxiety or trauma-related disorder that requires treatment. This non-specific diagnosis is a barrier to receiving appropriate evidence-based care as no treatment guidelines for unspecified anxiety exist. Psychiatric diagnosis is a complex and evolving process, and efforts to influence clinical decision making to improve the accuracy and timeliness of psychiatric diagnosis must first ascertain the specific factors in the diagnostic process where breakdowns occur. The proposed 3-year study will use mixed quantitative and qualitative methods to identify system-, provider-, and patient-level factors associated with diagnostic specificity for anxiety disorders in VHA mental health settings nationally. Understanding how these factors interact in the anxiety diagnostic process is crucial to identifying appropriate point(s) at which to intervene.